Research Supplement to Promote Diversity for Toolkit for Fast Multipurpose and Inducible Bioorthogonal Chemistry

Research Supplement to Promote Diversity for Toolkit for Fast Multipurpose and Inducible
Bioorthogonal Chemistry
The goal of this supplement to R01 GM132460 will be to extend the toolkit being developed under
the parent award to intersect with the goals of PA-23-189 by funding the research of graduate
student Ashley Sias. As an extension of the parent R01 Aim 3, the goal of this proposal is to
develop a diverse set of new chemical tools centered on Tetrazine Ligation—the fastest
bioorthogonal reaction. The technology developed in this proposal will improve the practicality,
generality, tunability and scope of tetrazine ligation. We propose to develop efficient catalytic
methods for ‘turning on’ and applying rapid bioorthogonal chemistry in biological context. A
mentoring plan and timeline are described that includes various mechanisms for research and
career development that will be supported by a mentoring team with both industrial and academic
experience.

Public health relevance
Project Narrative The goal of this adminstrative supplement will be to support a graduate student on the parent R01, which has the goal developing a diverse set of new chemical tools centered on tetrazine ligation– the fastest known bioorthogonal reaction. The work will advance new biotechnological, biomedical and pharmaceutical applications through new chemical tools for labeling biomolecules in the intracellular environment, new methods for selectively tagging and assembling proteins, and new technology for probing biological targets in living systems with spatiotemporal control.